Metabolic Monitoring System for Animal Models & Imaging Facility.

PROJECT SUMMARY/ABSTRACT
The West Virginia University Animal Models & Imaging Facility is requesting support to purchase a
Comprehensive Laboratory Animal Monitoring System (CLAMS) from Columbus Instruments. CLAMS is an
indirect calorimetry system for individually housed mice and rats that measures multiple parameters pertaining
to metabolism, including oxygen consumption and carbon dioxide production, XY activity and running wheel
rotations, food and liquid consumption, sleeping bouts and body mass. Together, this system allows researchers
to monitor energy expenditure in a variety of preclinical models. The AMIF currently has a 12-cage CLAMS
system for analysis of mice. The users have been averaging over 550 hours in CLAMS per month, and none of
them are able to get enough instrument time complete their NIH-funded projects. In addition, the current CLAMS
is a mouse-only setup, so while investigators using rat models have a need for metabolic studies, this system
cannot support their projects. Therefore, the Facility proposes to purchase a second CLAMS instrument to
increase availability, support larger cohorts of animals and expand the capabilities for metabolic monitoring in
rats to support and enhance the research capabilities at West Virginia University.

Public health relevance
PROJECT NARRATIVE A healthy, well-balanced metabolism is necessary to produce and store energy to support all aspects of life, but as a nation, we are suffering from an increase in metabolic disorders, including obesity and diabetes, cardiovascular disease, cancer, inflammation, and neurodegenerative diseases. The requested research instrument will allow us to monitor metabolism in a variety of preclinical models to identify targets for therapeutic intervention.